Maintenance and Continuation of the State of Maryland Rapid Response Team

Flexible Funding Model-Development and Maintenance of Human and Animal Food
Rapid Response Teams
Funding Opportunity: RFA-FD-23-019
Project Period: July 1, 2023 - June 30, 2026
Budget Period: July 1, 2023 - June 30, 2024
CFDA Number: 93.103
Maintenance and Continuation of the State of Maryland Rapid Response Team
ABSTRACT
The Maryland Department of Health (MDH), Prevention and Health Promotion Administration’s
Office of Food Protection (the Department) has made significant contributions towards the goal
of a nationally integrated food safety system (IFSS) through implementation of the
Manufactured Food Regulatory Program Standards (MFRPS) and creation and maintenance of
the State of Maryland Rapid Response Team (SMarRRT). This current proposal builds on the
successes and achievements of SMarRRT, by further integrating SMarRRT concepts,
operations, and partnerships into the Department, to achieve the following key goals:
1. Continue to work toward mutual reliance with the U.S. Food and Drug Administration
(FDA) to develop and implement an integrated food safety system in Maryland including
emergency preparedness and response to current and emerging food safety issues;
2. Continue the integration of SMarRRT with MFRPS through the incorporation of
additional food regulatory personnel to SMarRRT activities and practices;
3. Establish SMarRRT as a learning organization and a center of excellence on technical
aspects of the food industry committed to continued improvement and the
operationalization of an integrated food safety system;
4. Develop an information management infrastructure that is compatible with the National
Food Safety Data Exchange (NFSDX) and complements and enables the Department
and SMarRRT operational capacity through the effective management and presentation
of laboratory, geographic, regulatory, and compliance data; and
5. Continue to develop subject matter expertise in response related procedures such as
product and environmental sample collection, traceback investigation and data analysis,
environmental investigations and Risk Assessments.

Public health relevance
Flexible Funding Model-Development and Maintenance of Human and Animal Food Rapid Response Teams Funding Opportunity: RFA-FD-23-019 Project Period: July 1, 2023 - June 30, 2026 Budget Period: July 1, 2023 - June 30, 2024 CFDA Number: 93.103 Maintenance and Continuation of the State of Maryland Rapid Response Team Project Narrative The Maryland Department of Health, Prevention and Health Promotion Administration’s Office of Food Protection (the Department) seeks to maintain the State of Maryland Raid Response Team (SMarRRT) program. The purpose of the program is to continue to provide a multiagency, multidisciplinary team to manage and respond to intrastate and interstate food emergencies that impact Maryland. Since its inception in 2012, the team has managed and responded to many food related emergencies, creating standardized procedures to facilitate communication and increase efficiencies in responses and public health outcomes.